Reactivity-Activation of O(2) or NO in Copper and Heme-Cu Coordination Complexes

Project Summary/Abstract: This equipment supplement project proposal seeks funds to purchase a Cold-Spray Ionization Mass Spectrometer to carry out CSI-MS experiments, a powerful approach to characterizing typically unstable reactive intermediates. The scientific objectives include the design, synthesis & investigation of synthetic models which will aid the elucidation of fundamental aspects of structure, M-ligation, spectroscopy and reactivity relevant to copper and heme/M (M = Cu, Fe) processing of molecular oxygen (O2(g)) and nitric oxide (NO(g)). Copper proteins of concern include lytic polysaccharide monooxygenases, Cu-methane monooxygenases, the enzyme family which includes peptidylglycine monooxygenase, and a binuclear copper protein, NspF. Biochemical research has raised questions concerning the nature of their active sites and the mechanism(s) of action involving O2(g) activation and C-H hydroxylation. LPMOs may be peroxygenases, new pMMO studies suggest a mono-Cu active site, and it is now questioned as to whether DBM and PHM activate O2 with a Cu vs a Cu2 center. There are clear needs to synthesize and characterize the copper(II)-oxyl (CuII-O·) species; it has the oxidizing ability needed for the difficult biological substrates. We also plan to elucidate fundamentals critical to the O-O reductive cleavage process occurring in proteins which process O2. Also, we will generate and characterize the structures, physical properties and reactivity of new high-valent binuclear Cu(II)-O-Cu(III) complexes. Proposed research will also focus on the heme-copper active site of cytochrome c oxidases, where O2-binds and is reductively cleaved to give two mole-equiv water. The study of synthetic models aids an understanding of structure, O2-binding, proton or H-bonding facilitated O-O cleavage, and the role of the active-site phenol. Investigations are proposed to further investigate the mechanisms of O-O cleavage in heme-peroxo-copper constructs, where the porphyrinate, the Fe axial ligand and the copper ligand are systematically varied. A variety of planned approaches include study of new chelates for copper which possess three N-donors and an appended phenol. NO(g) synthetic model chemistry sub-projects with copper and heme-M will also be carried out. With Cu complexes, the focus will be on NO(g) reductive coupling, and study of mechanisms pertaining to the NO(g) metal-binding, formation of the N?N bond giving putative hyponitrite N2O22? intermediates, and proton and/or H-bonding contributions to N?O cleavage and N2O formation. Heme/Fe (or Cu) mediated NO(g) coupling is critical in NO-Reductases and synthetic models for this process will be investigated. Metal-peroxynitrite (PN, from metal ion + O2(g) + NO(g)) reactivity, especially toward CO2, will also be studied as relevant to biological activity.

Public health relevance
Project Narrative: The proposed research, with the addition of a Cold-Spray Ionization Mass Spectrometric instrument being requested here, addresses fundamental aspects of the chemistry of heme-iron with copper or non-heme iron with molecular oxygen and nitrogen oxides such as nitric oxide; the findings will contribute to a deeper understanding of the connection between heme, non- heme iron and copper biochemistries, and the manner in which they utilize these small molecule gases in cellular processes. The interactions of these biologically important small molecules with such metal dependent enzymes are critical in normal functioning and health. Potential long-term applications of this basic research include development of enzyme inhibitors as drugs and relevant disease therapeutic strategies.